WNPRC GENETICS SERVICES UNIT

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To provide core, campus and non-host investigators with sophisticated and specialized genetics resources and expertise.[unreadable] [unreadable] Progress and concerns[unreadable] [unreadable] In 2006, the Genetics Service established a high-throughput DNA sequencing facility. From May 1, 2006 to December [unreadable] 31, 2006, the sequencing facility processed more than 30,000 DNA sequences for 22 users. Sequence quality was high, [unreadable] with an average read length of more than 670 bases in December, 2006. Responding to the popularity of the service in [unreadable] 2006, we recently upgraded the sequencing hardware to double throughput and capacity. The Genetics Service also [unreadable] provides increasingly sophisticated MHC genotyping of WNPRC macaques. The tools developed for these analyses are [unreadable] now being adapted by outside investigators with WNPRC assistance.[unreadable] [unreadable] Allocation of resource access[unreadable] [unreadable] The Genetics Service sequencing facility was designed as an economical and rapid alternative to existing DNA sequencing [unreadable] services for nonhuman primate researchers with medium-to-high throughput needs. Current clients are drawn largely [unreadable] from WNPRC AIDS laboratories that perform extensive SIV and immunogenetics research.[unreadable] [unreadable] Dissemination[unreadable] [unreadable] We request that projects utilizing Genetics Service acknowledge the service in manuscripts and presentations. Dr. [unreadable] O'Connor, the PI for Genetics Services, lectures regularly on NHP genetics.[unreadable] [unreadable] Training[unreadable] [unreadable] All 22 users of the sequencing service received training in the submission and retrieval of data during 2006. A subset of [unreadable] these users obtained advanced training in the analysis of sequence data from Genetics Services staff. Additionally, [unreadable] methods for MHC genotyping macaques using microsatellite markers were provided to laboratories in the USA, UK, and [unreadable] Australia.